Scientific Core: Bacillus anthracis Anthrax Toxin Core

The role of anthrax toxin and the potential for using components of the toxin as an anthrax vaccine, are central to many of the proposed projects in this proposal. This core will provide investigators with highly purified anthrax toxin proteins that can be used consistently in large and small-scale studies. The toxin core will purify large amounts of PA, LF, and EF, that is LPS-free. Batches of toxin will be tested by the core for relative activity and normalized batches of toxin will be provided, so investigators can pursue multiple studies over the five years of this project confident in the consistency of this reagent. This core will also store and catalog PA, LF, and EF and employee a technician that will oversee the purification, characterization, and distribution of the toxin.

Public health relevance
Anthrax toxin is a major virulence factor of B. anthracis, and insights into this toxin and its contribution to disease help us better understand anthrax. This core will be a central source and repository that can provide highly purified anthrax toxin to investigators and facilitate their studies on this critical virulence factor.